Essentia Health Community Cancer Research Program - NCORP

PROJECT SUMMARY
The Essentia Health Community Cancer Research Program (EHCCRP) was originally funded by the
National Cancer Institute in 1984 under the former name Duluth CCOP. EHCCRP brings the benefits of
clinical research to patients in regions that would be without access to clinical trials due to the distance from
the nearest comprehensive cancer center. With successful competitive CCOP grant renewals in 1987, 1990,
1995, 2000, 2005 and 2010, as well as a successful NCORP grant in 2014, EHCCRP has proven to be a
sustainable and successful community oncology research program over the span of 34 years. Since the
NCORP grant inception in 2014, the EHCCRP has continued its expansion in rural communities by adding
additional affiliates and sub-affiliates. The EHCCRP catchment area now covers portions of five states (MN,
WI, MI, ND, SD). This large geographic area is predominantly rural and includes a number of American
Indian tribal communities. The strategy of the EHCCRP NCORP is to continue to offer patients in the region
access to state-of-the-art cancer care through participation in NCI supported treatment, cancer
control/prevention, screening, post treatment-surveillance, and imaging protocols. The NCORP grant will
support the infrastructure and personnel necessary to fulfill our proposed research strategy in our catchment
area. In addition, the EHCCRP NCORP will continue to develop a robust Cancer Care Delivery Research
(CCDR) program; to participate in NCI supported CCDR protocols. The Alliance for Clinical Trials in
Oncology will function as the primary research base for the EHCCRP and secondary research bases will
include the NRG, ECOG-ACRIN, SWOG, and Wake Forest. The EHCCRP NCORP will continue to open
trials through the Clinical Trials Support Unit of the NCI with full utilization of the central IRB. The goal of the
EHCCRP is to accrue 350 patients annually to treatment, cancer control, prevention, screening, imaging and
post-treatment surveillance protocols. EHCCRP CCDR infrastructure will grow over the coming NCORP
grant period to support 6 open CCDR protocols annually. A robust culture of cancer care that supports
multi-disciplinary treatments allows us to deliver the best possible therapy while maintaining a high level of
accrual to clinical trials.

Public health relevance
PROJECT NARRATIVE Enormous advances in cancer care have occurred due to NCI supported clinical trials which have resulted in substantial improvements in patient outcomes. The EHCCRP is a highly successful oncology research program that will continue to offer state-of-the-art cancer care and NCI clinical trials to patients in MN, WI, MI, ND and SD as part of the NCORP system.